Development of Deep Learning Tools for Widely-Available, Inexpensive Diagnosis of Coronary Microvascular and Vasomotor Dysfunction

Heart disease continues to be a leading cause of disability and death worldwide. Recent research has refined
our understanding of the many causes of heart disease and provided many new therapies to treat heart
disease. Coronary microvascular and vasomotor dysfunction {CMVD) is a condition that results from aging,
diabetes, obesity, hypertension, smoking, and other cardiovascular risk factors and is a common cause of
chest pain. Many studies have established that CMVD is associated with adverse cardiac outcomes, including
death. Indeed, CMVD is likely to be a causal contributor to epicardial coronary artery disease and vulnerable
atherosclerotic plaques through decreased wall shear stress. Despite this, standard testing modalities are
unable to consistenUy diagnose CMVD. Generally, CMVD is diagnosed with either expensive, specialized noninvasive
stress imaging modalities or even more costly invasive angiographic measurements performed with
intracoronary probes. As a result most CMVD diagnoses are presumptive-made after ruling out all other
possibilities. This is a cosUy approach with uncertainty for both patients and treating clinicians. Furthermore,
difficulty in establishing confirmed diagnoses of CMVD has been a critical impediment to the development of
novel therapeutic approaches to CMVD. Consequently, there is a major unmet clinical need for a simple,
readily available, and inexpensive diagnostic test for CMVD. The primary aims of this project will be to develop
and validate artificial intelligence methods and computer software tools for noninvasive diagnosis and
characterization of CMVD. Artificial intelligence methods are able to identify subtle features in complex data
that are sometimes difficult or time-consuming for physicians to see. The long-term objective is to develop and
commercialize such tools to facilitate improved management of patients with myocardial ischemia without
obstructive coronary artery disease, to guide and monitor treatment of such patients, and to provide tools to
enable the development of novel therapeutic approaches for CMVD.

Public health relevance
Project Narrative Heart disease remains a leading global health challenge, with coronary microvascular and vasomotor dysfunction (CMVD) being a signiﬁcant yet diﬃcult-to-diagnose contributor to this burden. Standard tests often fail to detect CMVD, leading to presumptive diagnoses after excluding other conditions, which hinders the development of new treatments. Addressing this gap, the project aims to create and validate AI-driven software for the noninvasive diagnosis of CMVD, potentially revolutionizing patient management and therapeutic innovation.